Project-003

The UTMB CTSA hub workforce development (WFD) objective is to create and sustain a diverse, robust
multidisciplinary workforce with the skills, knowledge, and institutional environment necessary for continuous
improvement in clinical and translational biomedical research. The new and existing competency-based
educational and training opportunities described below are designed to be accessible, relevant and address
learner-specific needs at all career stages, by being fully integrated with other U54, TL1 and KL2 workforce
development components, and by engaging not only physician scientists and translational scientists, but also
research coordinators, nurses, and other allied health professionals. Aligned with the strategic goals of our
CTSA and domains of activity prioritized by NCATS, we will offer both on-site and on-line opportunities for
training in team science (e.g., TeamMAPPS), team leadership (e.g., Leadership Challenge Program), medicaland
bio-informatics (e.g., Foundations of Medical Informatics), entrepreneurship (e.g., TREx), communityengaged
research, and the regulatory and ethical issues associated with human-subjects research and clinical
trials (e.g.,Clinical Research Practicums). Our Clinical and Translational Research Pilot (CTRP) program brings
together research resources and invests in them to advance team-based science that is aligned with institutional
and national priorities. Our CTRP program continues to enrich new collaborations within our CTSA as well as
to collaborate with other Universities and CTSA programs. Our goal is to award pilot projects that aptly reflect
CTSA priority areas including translation of novel discoveries to improve patient care while understanding and
addressing the organizational challenges underlying each stage of the translational process (i.e., implementation
science). Towards these ends, our CTRP program will leverage the diverse strengths of our mentors, multidisciplinary
teams and unique academic partnerships. Our clinical trials studio will assist investigators, as a frontdoor
mechanism, to facilitate rigorous study design and application, by ensuing that our new clinical investigators
have the essential skills to conduct their research using good clinical practice (GCP) standards. Additionally,
the CTRP program will aim to include community engagement core in order to best disseminate translational
findings and to expand studies into the rural areas. Each year, CTRP pilots will be evaluated and awarded in the
following categories, 1) the pilot clinical trials [one - three per year] that represent successful translation for novel
discovery of devices and therapeutics, 2) co-sponsored CTSA pilot grants with UTMB academic partners [two
– four per year] and 3) to support a new MTT [one per year] that are designed to foster unique opportunities for
scientific advancement and team growth. Additionally, vouchers will be administered with a special focus on new
investigators to conduct feasibility trials. Evaluation of all WDF and CTRP progress will use common metrics
(e.g., new manuscripts, extramural funding, and intellectual property) as well as other validated assessment
tools and deliverables.